Chronic Kidney Disease in Children (CKiD IV)

PROJECT SUMMARY
The Chronic Kidney Disease in Children Study (CKiD) is a multi-center, prospective, observational cohort study
of children aged 6 months to 16 years with mild to moderately impaired kidney function at study entry. Two
clinical coordinating centers (CCCs) at the Children's Hospital of Philadelphia (CHOP), and Children's Mercy
Hospital (CMH), and a data coordinating center at Johns Hopkins Bloomberg School of Public Health have
formed a cooperative agreement to conduct this study. Since its inception in 2003, the scientific aims of CKiD
have been to determine the risk factors for decline in kidney function and the effects of kidney function decline
on the risk factors for cardiovascular disease, growth failure and its associated morbidity, neurocognitive function
and behavior. The purpose of this application is to request funds to continue the cohort study from August, 2018
to July, 2023. The aims of the current proposal will expand on the original aims to include completion of
recruitment of 190 children with congenital anomalies of the kidney and urinary tract and other non-glomerular
kidney disorders early in the course of CKD, characterization of the impact of duration of CKD, dialysis and
kidney transplantation on the cumulative burden of cardiovascular risk factors, remote assessment of physical
activity and blood pressure, development of novel approaches to identify risk factors for CKD progression,
enhancement of research in childhood CKD through collaboration with other cohorts, and continued provision of
a broad data resource for the scientific community. The Principal Investigator of the Midwest Clinical
Coordinating Center at CMH has clinical expertise in kidney disease in children, clinical research design,
recruitment and retention, quality control of study procedures, and organization of collaboration across the
multiple participating sites in CKiD. The CKiD study encompassess a geographically and racially diverse cohort.
The structure of CKiD and its support of ancillary studies continues to stimulate the generation of new knowledge
pertaining to the progression of CKD and the development and evolution of associated co-morbidities, as well
as the publication of those data. The infrastructure of CKiD continues to serve as a platform for career
development awards for junior investigators, and ancillary R01s for more senior colleagues. Most importantly,
with longer follow-up and additional recruitment of subjects early in the course of CKD, we will contiune to
characterize novel biomarkers of kidney inury that are associated with CKD progression and its sequellae to help
inform future therapeutic trials.

Public health relevance
PROJECT NARRATIVE Children with chronic kidney disease (CKD) pose unique challenges to the health care system, which must address not only the primary kidney disorder, but the many extrarenal manifestations which include growth, neurocognitive development, risk for cardiovascular disease and a high mortality rate in young adulthood. The CKiD study is a landmark cohort study of children with CKD, having rallied 54 pediatric nephrology centers across the US and Canada to recruit and study over 900 children with mild to moderate CKD. From 2018 to 2023, the Midwest Clinical Coordinating Center will continue to coordinate the study visits in their CKiD participating sites, with the following long term goals: characterization of the impact of duration of CKD, dialysis and kidney transplantation on the cumulative burden of cardiovascular disease risk factors, development of novel approaches to identify risk factors for CKD progression, enhancement of research in childhood CKD through collaboration with other patient cohorts, and continued provision of a broad data resource for the scientific community.